The impact of age-related changes in osteoclast function on the skeleton

Abstract
Age-related bone loss puts individuals at risk for debilitating osteoporotic fractures. Current osteoporosis
therapies primarily target bone-resorbing osteoclasts to prevent further bone loss; however, because of the
coupling of osteoclasts and osteoblasts, these therapies are limited by a concomitant decrease in bone
formation. Thus, new treatments are needed to reduce bone loss while protecting or stimulating new bone
formation. Osteoclasts are multinucleated cells derived from the myeloid lineage. While most well-known for
bone resorption, osteoclasts exhibit a range of functions, including stimulating bone formation by osteoblasts
(coupling activity). Increasing evidence shows that osteoclasts exhibit functional heterogeneity. Our data
presented herein confirm that not all osteoclasts are actively resorbing or coupling, and others have documented
heterogeneity in osteoclast resorptive activity itself. With aging, there is a shift in osteoclast functional distribution,
with an increase in the percentage of actively resorbing osteoclasts and a decrease in osteoclasts positive for
coupling factor expression. Aging also leads to an increase in an aggressive subpopulation of osteoclasts, which
move while resorbing bone leading to trench formation. Our data support that these aggressive, trench-forming
osteoclasts, which exhibit greater acidification of the resorption lacunae and increased protease activity, have
impaired ability to recruit osteoprogenitors to sites of resorption. Therefore, we hypothesize that the increase in
aggressive, trench-forming osteoclasts with age is linked to reduced osteoclast coupling activity, leading to
overall bone loss. To test this hypothesis, we propose to 1) Determine whether inducible activation of osteoclast
coupling activity prevents age-related bone loss.; 2) Evaluate whether differential osteoclast resorptive
behaviors impact coupling; and 3) Test the role of matrix-derived TGF-β as a feedback mechanism to
modulate osteoclast activity. Altogether, these studies will reveal the distribution of osteoclast behaviors and
how these are dysregulated during aging. In addition, understanding the mechanisms by which changes in
resorption contribute to altered coupling activity will reveal potential new therapeutic targets for shifting osteoclast
activities to treat osteoclast-mediated bone disease.

Public health relevance
Project Narrative Osteoporosis affects approximately 10 million Americans, while another 34 million are suspected to have low bone mass putting them at risk for developing the disease. The majority of current osteoporosis therapies reduces the number of bone resorbing osteoclasts, and as a result, indirectly reduces new bone formation. Successful completion of this project will provide fundamental insights into the mechanisms that modulate individual osteoclast activities in order to develop novel osteoporosis therapies that reduce bone loss while preserving bone formation.